CE24-001, ICRC, MCW CIC CENTER GRANT: WORKING TOWARDS HEALTH EQUITY IN INJURY PREVENTION

PROJECT SUMMARY
The prevention and control of injury disparities is one of the major public health challenges of this
century. The Comprehensive Injury Center (CIC) at the Medical College of Wisconsin is
committed to reducing the burden and disparity of injuries and violence through trans-disciplinary
collaborations that bring together expertise and resources to advance innovative and novel
approaches to injury prevention and control and maximize their effect. The CIC's goals are to: 1)
Advance the science of health equity in injury prevention and control by facilitating, conducting,
and disseminating interdisciplinary translational research that leads to novel findings across all
levels of prevention for populations who experience or are at risk for injury-related health
disparities; 2) Develop, implement, and evaluate multi/inter-disciplinary educational opportunities
that emphasize health equity to educate and train both current and the next generation of injury
prevention researchers, practitioners, and educators, as well as community partners and leaders;
and 3) Maintain, develop, and foster model partnerships for the health and safety of
marginalized populations at greatest risk for injury disparities, including partnerships with public
health organizations, community groups, as well as other public and private sectors and systems
that facilitate, translate, and disseminate evidence-based injury prevention and control programs
and policies.
To achieve these goals, the CIC will support and integrate outreach, training, and research to
address the NCIPC and NCIPC Director's priorities and facilitate the translation of research to
practice for those experiencing injury disparities. The proposed research projects will impact injury
and violence prevention and control to achieve health equity by: 1) addressing health equity and
barriers to access to care in emergency departments for mild traumatic brain injury; 2)
investigating the role that police violence has in risk for suicidal thoughts and behaviors in young
Black men; 3) evaluating the intersectionality of race, socioeconomic position, and alcohol in risk
for firearm related suicide and homicides; and 4) determining the role of detoxification in
preventing or contributing to opioid overdose and how race and socioeconomic position play a
role in treatment. Together, these research projects will make a significant impact on advancing
our understanding of how prevention efforts can reduce disparities in marginalized people and
communities.

Public health relevance
PROJECT NARRATIVE Preventing violence and injury disparities to achieve health equity is one of the major public health challenges of this century. The Comprehensive Injury Center (CIC) at the Medical College of Wisconsin provides an outstanding environment to initiate, conduct, and evaluate injury research, education and training, and outreach, to reduce the burden and disparity of injury in communities, states, and across the country. The CIC will support and integrate core programs and research projects to facilitate the translation of research to practice in order to reduce the burden of injury in vulnerable individuals, communities, and populations.